Development of Novel Therapeutic Strategies in Human Leukemias

Overall Program Abstract
Our proposal addresses fundamental challenges in the treatment of AML, building on recent advances in drug
development and new discoveries in leukemia biology, genetics, and epigenetics. We will systematically study
regulators of normal and malignant hematopoiesis, leveraging expertise in BH3 profiling to identify compounds
that shift cellular apoptotic threshold (Dr. Anthony Letai), by developing protein degradation as a novel tool to
overcome gaps in the druggable proteome (Drs. Benjamin Ebert, Eric Fischer, and Scott Armstrong), and by
discovering and developing novel agents to target a variety of dependencies in leukemia, including epigenetic
programs (Dr. Armstrong and Dr. Zuzana Tothova).
The Program includes productive investigators with an enduring history of collaboration. Through this program,
our investigators have led research bringing FLT3 and BCL-2 inhibitors from basic science through to FDA
approval for the treatment of AML, have carved out a whole new field drugging the undruggable using targeted
protein degradation, and have led DOT1L and Menin inhibitors into clinical trials for patients with for KMT2A-
rearranged, NPM1 mutant and NUP98-rearranged leukemias. The proposed projects will exploit major
advances in cancer biology, genetics and epigenetics, and drug discovery.
To improve on current treatment for leukemia, we will focus on three central themes: (1) Cellular regulation in
normal and malignant hematopoiesis. We will study the biology and genetics of hematopoiesis, and evaluate
the therapeutic potential in four different areas: mitochondrial sensitivity to the FS-1 BH3 mimetic for BFL-1
inhibition (Project 1), the molecular basis for MYB degradation in response to microtubule destabilization
(Project 2), the regulation of KMT2A complex formation and gene expression by Menin (Project 3), and the
effects of transcription-coupled DNA-RNA hybrids (R-loops) on chromatin organization and gene regulation
(Project 4). (2) Targeting ubiquitin ligase function. Our laboratories have characterized several novel
mechanisms of drug-induced degradation of hematopoietic transcription factors with direct therapeutic
applications. We will leverage our aggregate expertise in cancer biology, proteomics, genetics and
epigenetics, and ubiquitin ligase biology and chemistry to discover and characterize novel protein degraders to
target apoptosis, through disruption of BFL-1, MYB degradation via microtubule destabilization, and chromatin
maintenance by Menin/KMT2A degradation. (3) Genetic and molecular susceptibilities to therapies. Along with
investigating the apoptotic pathways, genetic programs, and chromatin regulatory networks (epigenetics) that
contribute to leukemic proliferation, we will focus on the discovery and development of targeted inhibitory and
protein degrading compounds and determine their optimal use singly or in combination in AML.

Public health relevance
Overall Project Narrative Our proposal aims to address fundamental challenges in the treatment of AML by building on recent advances in understanding the biology and treatment of myeloid malignancies. We will study key mechanisms of hematopoiesis and cellular regulation by leveraging expertise in BH3 profiling to identify compounds that shift cellular apoptotic threshold, developing protein degradation as a novel tool to overcome gaps in the druggable proteome, and by discovering and developing novel agents to target a variety of dependencies in leukemia. Along with investigating the apoptotic pathways, genetic programs, and chromatin regulatory networks (epigenetics) that contribute to leukemic proliferation, we will focus on the discovery and development of targeted inhibitory and protein degrading compounds and determine their optimal use singly or in combination in AML.